Structure and Function of Pentameric Ligand-gated Ion Channels

PROJECT SUMMARY/ABSTRACT
The overarching objectives of this research program are to determine the molecular basis of allosteric
mechanisms that govern gating and modulation in pentameric ligand-gated ion channels (pLGICs). The pLGIC
superfamily governs crucial physiological processes such as gastrointestinal functions, motor coordination, and
pain transmission. Aberrant channel functions are implicated in neurological disorders, addiction, and chronic
pain. Currently used therapeutic strategies suffer from our limited knowledge of pLGIC assemblies in their native
environment, the origin of their functional diversity, and the downstream regulatory events. Over the last five
years, we have made significant discoveries in two pLGIC members- serotonin (3) receptor (5HT3R), an
excitatory channel, and glycine receptor (GlyR), an inhibitory channel. We have determined molecular details
of neurotransmitter recognition, channel gating, desensitization, and drug modulation. Building on these
advancements, we will probe the architecture and functional mechanisms in heteromeric pLGIC assemblies
and dig deeper into their post-translational regulation and functional interactomes comprising of synaptic binding
partners. To achieve these goals we will use cutting-edge multidisciplinary techniques, including cryo-electron
microscopy (cryo-EM), protein dynamics measurements, mass spectrometry, molecular dynamic simulations,
and electrophysiology. Taken together, our proposed work is expected to provide molecular blueprints of the
channel in physiologically relevant conformations for therapeutic targeting and unravel mechanisms underlying
channel function. These findings will in turn pave the way for the design of novel therapeutic agents that are
safer and more effective.

Public health relevance
PROJECT NARRATIVE The pentameric ligand-gated ion channels (pLGICs) mediate fast synaptic transmission in the central and peripheral nervous systems and hence, critically govern numerous cellular processes such as pain perception, motor coordination, and gastrointestinal functions. Dysfunctions in pLGICs are associated with several psychiatric, neurological, and gastrointestinal disorders. The goal of the proposed studies is to elucidate fundamental mechanisms governing channel function and modulation at a molecular level, and thereby aid drug development strategies.